Mechanisms underpinning meiotic spindle formation and behavior

Project summary
Meiosis is a specialized set of cell divisions that produce haploid gametes. During meiosis I (MI) in females,
bipolar spindle formation and positioning within the oocyte must be regulated tightly to ensure faithful
chromosome segregation and proper genome inheritance. In somatic mitotic cells, bipolar spindle formation
and positioning rely on a centrosome pair, each of which contains two centrioles. Interestingly, meiotic oocytes
lack centrioles and, hence, lack classic centrosomes. Meiotic oocytes, instead, contain numerous microtubule
(MT) organizing centers (MTOCs) that are organized, by largely unknown mechanisms, to establish two
spindle poles (polar MTOCs). The traditional view was that, in mammalian oocytes, MTs (and their associated
proteins) are the only cytoskeletal components responsible for organizing such MTOC spindles. However,
recent data suggest that F-actin is also involved in spindle bipolarity regulation. How F-actin interacts with MTs
to regulate polar MTOC organization during MI represents a critical gap in our understanding of how the
meiotic spindle is built. We recently identified a novel, functionally different, class of MTOCs (mcMTOCs) and
found that spindle maintenance at the oocyte center is regulated by two opposing forces (mcMTOC-mediated
MTs vs. F-actin). We also recently observed that ~50% of spindles are not assembled centrally. To date, such
peripheral spindle assembly was unobservable owing to technical limitations associated with spindle
fluorescence (i.e. live imaging). To circumvent this, we generated a Cep192-eGfp reporter mouse model
enabling spindle tracking wherever it is assembled. Strikingly, peripheral spindle formation is typically followed
by spindle migration towards the center – a previously undocumented phenomenon. Understanding the
molecular mechanisms regulating this corrective developmental event represents a major gap in our
knowledge of meiotic spindle spatiotemporal regulation during MI. This proposal lays the foundations for our
long-term goal: To understand how two critical events during MI — bipolar spindle assembly and positioning —
are regulated, in the absence of centrioles, to ensure faithful chromosome segregation. To do so, we will utilize
state-of-the-art approaches, including transgenic mouse models, genetic constructs, laser ablation, and
cutting-edge imaging, to tackle three critical goals: (i) determine how F-actin interacts with MTs to organize
polar MTOCs during bipolar spindle building, (ii) establish the mechanism(s) by which the peripheral
acentriolar spindle migrates to the oocyte center, and (iii) determine whether differences in biochemical
compositions of mcMTOCs vs. polar MTOCs underlie their functional differences. Given that chromosome
segregation errors (very common during MI) lead to aneuploidy, the leading genetic cause of developmental
disorders and miscarriage, these studies have the potential to significantly advance our basic understanding of
two fundamental processes — spindle formation and positioning — during MI whilst simultaneously shedding
light on why MI is notoriously error prone.

Public health relevance
Relevance to Public Health Meiosis is a specialized set of cell divisions that generate male (sperm) and female (egg) gametes. In females, meiosis is associated with high rates of chromosome segregation errors, which lead to miscarriage, infertility, and developmental disorders such as Down’s syndrome. This project uses mouse oocytes as a model system to understand the basic molecular mechanisms that regulate female meiosis, thereby shedding a light on why this process is notoriously error prone.